Understanding the Role of Structural Oppression for Suicide Risk among Black Sexual and Gender Minority Adolescents and Young Adults

PROJECT SUMMARY/ABSTRACT
Black sexual and gender minority (SGM) adolescents and young adults (AYA) face profound and increasing
suicide inequities. Evidence indicates differences in individual risk factors (e.g., mood disorders, substance
use) do not account for these suicide inequities. As such, there is a need to move beyond models of individual-
level causes of population-level inequities to identify and intervene upon the socio-structural drivers of suicide
among Black SGM AYA. Specifically, longitudinal research is needed to highlight sources of structural racism,
anti-SGM stigma, mental health stigma, and their intersections that affect suicidal thoughts and behaviors
(STBs) among Black SGM AYA, and to translate these findings into public health policy intervention. We are
submitting this application in response to RFA-MH-22-140 Understanding Suicide Risk and Protective Factors
among Black Youth (R01). We propose to build from an existing infrastructure supporting our U.S. national U-
award study (UG3AI169655), to enroll a national cohort of 1,000 Black SGM from ages 16 to 24, which would
be one of the largest Black SGM AYA national cohorts of its kind. We will use a combined approach to
recruitment (e.g., digital recruitment techniques, school-based recruitment) that capitalizes on community-,
school-, and internet-based networks maintained by our community collaborators. Participants will complete a
web-based survey annually for three years that assesses STBs, microsystemic suicide precursors
(interpersonal risk factors [thwarted belongingness, perceived burdensomeness], suicide prevention resources
[access to psychotherapy, access to community-based SGM support]), STB correlates (e.g., interpersonal
stigma, anxiety, substance use), and key sociodemographic and contextual variables. In tandem with study
enrollment, our multidisciplinary team of oppression and suicide researchers, psychological care providers,
policy experts, and community-based collaborators will develop a database of novel quantitative structural
oppression metrics (e.g., state-level policy and social climate indicators), including developmentally-specific
forms of structural racism, anti-SGM stigma, mental health stigma, and their intersections that target Black
SGM AYA (Aim 1). We will subsequently utilize these metrics and the longitudinal follow-up data to test
whether there are direct associations from structural oppression to later STBs (Aim 2). We will also use these
data to test indirect associations from structural oppression to STBs through increased interpersonal suicide
risk factors (thwarted belongingness, perceived burdensomeness; Aim 3a) and decreased access to suicide
prevention resources (psychotherapy, SGM AYA social services; Aim 3b). Developing and testing a socio-
structural model of suicide risk meets the calls of the 2019 Congressional Black Caucus Taskforce “Ring the
Alarm” report and has strong potential to move the field beyond individual-level models of risk to support the
structural change that will help to reduce population-level Black SGM AYA suicide inequities.

Public health relevance
PROJECT NARRATIVE Despite recent evidence that Black sexual and gender minority (SGM) adolescents and young adults (AYA) are at inequitable and increasing suicide risk, little research has examined forms of structural oppression as drivers of these trends. In this study, we will establish a large nationwide cohort of Black SGM AYA and follow them longitudinally to examine socio-structural predictors (e.g., state laws, policies, and social climate indicators of racism, anti-SGM stigma, mental health stigma, and their intersections) of suicide thoughts and behaviors (STBs) and proximal mediators of STBs. We will integrate Intersectionality frameworks and the social ecological model to identify modifiable socio-structural targets for future transformational public health policy and community-level intervention that reduce population-level suicide inequities for Black SGM AYA in line with the 2019 Congressional Black Caucus Taskforce “Ring the Alarm” report’s call to action.